Molecular mechanisms for neuron-specific assembly of electrical synapses

SUMMARY
Gap junctions or “electrical synapses” mediate the flow of ions between neurons and are thus
essential to normal brain function. Circuit activity is defined by the selective placement of
electrical synapses between specific neurons and in particular cellular compartments.
Although much has been learned about the mechanisms that direct assembly of chemical
synapses between specific neurons, little is known of the pathways that drive the creation of
neuron-specific electrical synapses. With its stereotypical placement of gap junctions and
powerful tools for genetic analysis and imaging, the C. elegans motor circuit offers a unique
opportunity to investigate gap junction specificity. VA and VB motor neurons are connected via
gap junctions to command interneurons (AVA or AVB) that drive backward (VAàAVA) or
forward (VBàAVB) locomotion. Notably, VAàAVA gap junctions are placed on the VA axon
whereas VBàAVB gap junctions are positioned on VB cell soma. The UNC-4 transcription
factor functions in VAs to preserve VAàAVA electrical synapses; unc-4 mutants adopt
VAàAVB gap junctions on VA cell bodies and are thus unable to move backward. Thus, UNC-
4 regulates a transcriptional program that defines both the cellular compartment and neuron-
specificity of gap junction placement. We used VA-specific RNA-Seq data to reveal that UNC-
4 blocks expression of a phosphodiesterase, PDE-1, that degrades cAMP, and a neuropeptide
receptor, FRPR-17, that functions in a GaO pathway that antagonizes cAMP synthesis. Aim 1
tests the hypothesis that UNC-4 represses specific downstream targets to maintain cAMP
which in turn sustains VAàAVA gap junctions. Our RNA-Seq data revealed that another UNC-
4 target, the atypical kinesin VAB-8, is ectopically expressed in unc-4 mutant VAs where it
antagonizes normal trafficking of gap junction components into the VA axon. Aim 2 tests the
hypothesis that VAB-8 binds to microtubules to block the anterograde function of kinesins that
drive gap junction transport, thus, facilitating the formation of VAàAVB gap junctions on VA
cell soma. Aim 3 uses single molecule imaging techniques to test a “blockade” model in which
VAB-8 lacks ATPase/motor activity but binds to microtubules to impair gap junction export from
the cell soma. Although studies in cultured mammalian cells have implicated cAMP signaling
and trafficking in gap junction assembly, these pathways have not been tested for functional
roles in neuron-specific placement of electrical synapses in an intact nervous system. Thus,
our work with a model organism could provide important clues to fundamental processes
governing the formation electrical synapses in the human brain.

Public health relevance
Project Narrative Nerve cells (neurons) project elongated processes (axons) from the brain into the spinal cord to make connections (synapses) with motor neurons that drive movement. To identify genes that control the specificity of these connections, we are using the nematode C. elegans, a model organism with a simple, well-defined nervous system. The results of this work should reveal similar human genes with crucial roles in the creation spinal cord circuits and therefore potentially contribute to the development of treatments for spinal cord injury and dysfunction.